Building BRIDGES: Coordinating the Dissemination and Training for Biomedical Artificial Intelligence

PROJECT SUMMARY (ABSTRACT)
The growing intersection of computing, biomedical/behavioral research, and healthcare is expected to accelerate
with the advances in artificial intelligence (AI) and novel applications of data-driven methods. It is imperative that
we bring together leaders in these different areas, fostering interdisciplinary opportunities for sharing new ideas
and conversations to shape the appropriate use of AI, particularly in relation to health. For three decades, the
Association for Computing Machinery (ACM)’s Knowledge Discovery and Data Mining (KDD) conference has
been a leading international scientific conference for computer science. Recognizing how computing could help
improve biomedical research, health, and healthcare, KDD created KDD HealthDay, a forum to showcase and
advance how AI-driven knowledge discovery can address some of the most pressing challenges in medicine,
ranging from personalized medicine through to large-scale public health initiatives.
The goal of this supplement is to highlight aspects of NIH’s Bridge2AI program, as well as other major US-funded
AI programs, as part of KDD HealthDay 2025. Through this supplement, three sessions will be established: 1)
Strategies for Advancing Health AI, which will entail a panel involving national leadership spearheading major
health-related AI initiatives; 2) Pillar Programs Transforming Biomedical AI, which will paint a picture of the cur-
rent achievements of various national programs to advance AI-empowered biomedicine, as well as the current
barriers; and 3) Embracing AI Innovations and Implementation in Biomedicine and Healthcare, which looks to
the transformative potential of AI in domain-specific areas of healthcare delivery, biomedical/ pharma/health in-
dustries. This coordinated sequence of sessions will be further bolstered by a planned KDD Cup data competition
involving datasets from a Bridge2AI Grand Challenge. Collectively, these activities will provide further dissemi-
nation of NIH’s Bridge2AI signature program on a global scale.

Public health relevance
PROJECT NARRATIVE As evidenced through the signature programs by the National Institutes of Health (NIH) and other groups, artifi- cial intelligence (AI) methods are transforming biomedical research and healthcare, providing novel insights and applications that are reshaping scientific discovery and healthcare delivery. This endeavor will support dissemi- nation of Bridge2AI and other national programs’ AI-related efforts at a global level, enabling a community of leaders to showcase and discuss initiatives, achievements, and challenges of AI within biomedical and health- related venues at the Association for Computing Machinery (ACM) Knowledge Discovery and Data Mining (KDD) 2025 conference. The efforts in this project will support sharing and outreach across different stakeholders (ac- ademia, industry, government, etc.) to strengthen the impact of Bridge2AI and federal AI programs by engaging experts in a broadly recognized top scientific meeting.